Roles for Mismatch Repair Proteins in Maintaining Genome Stability

Project Summary
DNA mismatch repair (MMR) systems act to excise misincorporation errors that occur during DNA replication.
In eukaryotes MSH proteins recognize these errors in the context of base-base and insertion/deletion
mismatches and recruit MLH complexes to form ternary complexes that work with replication factors and Exo1
to excise the newly replicated DNA strand through the mismatch site. This is followed by DNA re-synthesis
steps. MMR factors also recognize mismatches that form during strand invasion steps in homologous
recombination; they recruit a helicase complex that unwinds (rejects) recombination intermediates and allows a
new homology search. Sydney Rosen's summer research is aimed at understanding the decision steps that
take place during homologous recombination when a double-strand break occurring in a DNA sequence is
repaired using a donor sequence containing low levels of sequence divergence (Project 3 in parent grant
R35GM134872). More specifically, she is interested in understanding how the kinetics and subnuclear
location(s) of homologous recombination in S. cerevisiae compare when an identical donor sequence is used
as a template for repair versus a divergent donor template. She plans to track and measure the timing of repair
of an induced DSB via a fluorescence-marked protein involved in homologous recombination (Rad52) as well
as nuclear pore components. Her hypothesis is that recombination between divergent sequences will result in
slower repair and possibly differences in repair location. Results from this time course will provide a better
understanding of how the rejection decision is facilitated, and how chromosomal rearrangements can lead to
disease. Sydney has expressed strong interest in entering a Ph.D. program in molecular biology after
graduating from Cornell. She will become experienced transforming baker's yeast and analyzing transformants
using western blot analysis and fluorescence and confocal microscopy. She will also learn the appropriate
statistical analyses for each of her experiments. Her mentors will meet with her daily to discuss her research
progress and plan future experiments. She is already an active participant in group meeting and journal club,
presenting research summaries and formal presentations. Over the summer Sydney will join our department's
summer Research Experience for Undergraduates (REU) program where she will gain experience presenting
her work in written and oral formats.

Public health relevance
Project Narrative Distinct groups of eukaryotic DNA mismatch repair (MMR) family proteins facilitate crossing over between homologs to ensure proper Meiosis I chromosome segregation, and act to prevent recombination between divergent DNA sequences that can lead to chromosomal rearrangements associated with diseases such as cancer. Importantly, mutations in MMR genes have been found in about half of hereditary non-polyposis colorectal cancer (2-7% of all colon cancers) patients, and are also linked to infertility, underscoring the importance of obtaining new mechanistic understandings and molecular tools to establish allele pathogenicity.